Commercialization Readiness Pilot for Flow Acceleration for Stroke Thrombolysis (FAST) System

Acute ischemic stroke (AIS) results from a blood clot in the neurovasculature and is the 5th leading cause of
death and 1st leading cause of neurological disability in the United States (US). AIS impacts 700,000
Americans each year, with a 65% chance of death or severe disability. By 2030, the AIS economic burden will
exceed $180B in the US alone. Standard of care AIS therapies include thrombolysis using alteplase (i.e.,
tissue plasminogen activator, tPA) within 4.5 hours of stroke onset and earliest possible thrombectomy for
large vessel occlusions (out to 24hrs). In contrast to thrombectomy, thrombolysis does not require confirmation
of a vessel occlusion. Because only ~10% of AIS victims are eligible for thrombectomy, thrombolysis remains a
critical first line tool to treat those diagnosed with AIS. When employed, thrombolysis is associated with a
~15% improvement in stroke outcomes with ~10% fully recovering. However, due to the ~7% dose-dependent
associated hemorrhage rate of alteplase, thrombolysis is contraindicated for mild and wake-up strokes which
together make up ~60% of all AIS events. Due to safety concerns and limited reliability, usage of thrombolysis
in the US remains low (~10%) with 90% of all AIS victims receiving only palliative care. There remains an
urgent need to improve first line use of thrombolysis which can be expanded to all AIS victims.
UN&UP has invented a novel adjunctive thrombolysis platform to safely accelerate alteplase to the
obstructing blood clot, thereby overcoming the restrictive hemodynamics known to prevent alteplase from
quickly reaching the occlusion. The proposed magnetic infusion platform overcomes this barrier by 1)
adjunctively conveying alteplase to the clot’s surface more than 100X faster than normal biological diffusion
(i.e., minutes vs. hours), and 2) mechanically mixing alteplase at the clot’s surface so that clots lyse faster.
Because alteplase is not conjugated and the mode of action is purely mechanical in nature, FDA meetings
support that a CDRH-led device pathway is appropriate in support of an IDE for an FDA Early Feasibility Study
(EFS), which is a shorter and less expensive pathway compared to a traditional CDER-led IND process.
Importantly, the technology is affordable, does not require precise focusing, and can be configured to travel
with patients transferred for thrombectomy. Once proven safe and effective using current FDA approved
alteplase labeling, UN&UP intends to expand thrombolysis to mild and wake up strokes by increasing the lysis
efficacy of smaller alteplase doses known not to induce hemorrhage. If successful, thrombolysis could be
safely extended to all AIS victims for the first time, which is 10X more than currently treated.
To help commercialize this novel technology, this project’s aim is to evaluate safety and efficacy using an
in vivo rat embolic middle cerebral arterial occlusion model at the Henry Ford Neuroscience Institute, which is
increasingly being used in support of FDA approvals for early clinical studies related to AIS.

Public health relevance
There are nearly 700,000 annual acute ischemic stroke (AIS) events in the US which result in more than 160,000 deaths, making AIS the fifth leading cause of death and the leading cause of neurological disability. Although thrombectomy is the standard of care for those diagnosed with a treatable large vessel occlusion in the anterior circulation, it is only used in ~5% of AIS events; thus, improvements in first-line thrombolysis are needed in that 1) thrombolysis currently results in only a ~10% chance of full recovery; 2) due to dose-related hemorrhage risks of thrombolysis, mild and wake-up strokes remain contraindicated for thrombolysis despite making up nearly 60% of all strokes; and 3) AIS patients who receive thrombolysis during transfer often arrive too late to benefit from thrombectomy. UNandUP (“UN&UP”, short for “Unmet Needs and Underserved Populations”) has invented a novel thrombolysis platform which promises to be more effective (by adjunctively lysing occlusive clots faster and more reliably) and safer (by subsequently lowering the systemic thrombolytic dose associated with hemorrhage), so that all AIS victims can be better treated.